Proteome-wide assessment of the impact of citrullination on the activityof transcription factors in Th2 cells

Project Summary
Many proteins are modified after they are produced in cells. Such modification can critically influence the
function of proteins. One such modification is citrullination, which has been shown to regulate the function of
immune cells, including lymphocytes and neutrophils. Abnormal citrullination has been associated with many
human diseases, including infection and autoimmune diseases. Thus, manipulating protein citrullination can be
beneficial in many clinical settings; however, our knowledge of citrullination is still very limited mainly due to
lack of reliable methods for examining the functional impact of citrullination. The objective of this project is to
develop a method that can be used to assess the proteome-wide impact of citrullination on the activity of
transcriptional regulators in immune cells. A DNA-proteomic platform will be optimized and subsequently used
to compare the activity of transcriptional regulators at a proteomic scale between citrullination sufficient and
deficient lymphocytes. The approach can be readily modified and applied to other immune cells. Results thus
generated very likely will lead to discoveries of novel therapeutic targets of human diseases.

Public health relevance
Project Narrative Many proteins are modified after they are produced in cells. One form of protein modification called citrullination is important for body's defense against invading microbia and also for proper function of cells. Development of a method that can simultaneously assess the effect of citrullination on the activity of a large set of proteins will markedly advance our understanding of how citrullination affects the function of human cells, and will uncover novel strategies of improving human health.